Role of C. elegans RAPGEF in Synapse Development at the Neuromuscular Junction

PROJECT SUMMARY/ABSTRACT
Synaptic dysfunction is a major contributor towards the development of a large range of neurological
disorders. For proper formation, synapses require a series of signaling pathways to guide them, but
not all of those pathways are well understood. Rap Guanine Exchange Factors, or RapGEFs, are
signaling proteins that act to accelerate the rate of activation of GTPases that achieve downstream
functions. RAPGEF subfamily members are associated with multiple neurological disorders, including
schizophrenia. In murine models, disruption of RAPGEF6 function results in reduced anxiety
behaviors, like that observed in patients with schizophrenia, and increased long term potentiation. In
addition, they found no changes in gross brain morphology. Although these studies suggest that
RAPGEFs modulate synaptic function, the exact mechanism is currently unknown. To address
whether loss of RapGEF function influences synapses, mutations within pxf-1, a C. elegans RapGEF
orthologue were studied. When exposed to the acetylcholinesterase inhibitor, aldicarb, pxf-1 mutants
displayed decreased sensitivity indicating altered synaptic function. Additionally, pxf-1 and rac-2
GTPase mutants display decreased synaptic vesicle intensity in cholinergic synapses. Based on
these preliminary findings, the central hypothesis is that PXF-1 alters cytoskeletal reorganization
within neurons to influence synaptic formation and accomplishes this through activation of Rac
GTPase signaling. To test this hypothesis, this study will use the C. elegans neuromuscular junction.
C. elegans are an advantageous model system for the study of neuronal function due to their well-
defined genome, translucent body for imaging techniques, and overall ease of genetic manipulation.
The goal of this project is to determine the mechanism of PXF-1 function within the neuromuscular
junction through the following aims. Aim 1. To identify the downstream GTPase that PXF-1 is
activating in this pathway. Aim 2. To investigate whether inhibiting a GAP protein in the PXF-1
pathway can restore synaptic development and function. Overall, this research will provide insight into
the molecular mechanisms that govern synaptic formation and how their dysregulation may lead to
development of disorders. This research will support the development of future treatments for
synaptopathologies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because synaptic dysfunction is associated with many neurological disorders that lack effective therapeutic options. Moreover, understanding the signaling proteins that promote synaptic development will provide significant advances in our knowledge of how the nervous system is organized. Therefore, the proposed research is relevant to NIH’s mission to seek fundamental knowledge about living systems and to reduce illness and disability.